GH21-004, COVID-19 and related public health threats in populations affected by crises: a multi-disciplinary, collaborative research programme

Project summary / abstract
In response to the Centers for Disease Control and Prevention’s Notice of Funding Opportunity to conduct
research among crisis-affected and displaced populations in the context of COVID-19, we hereby propose a
five-
year programme of research and capacity strengthening
, focussed on
four key crisis-affected countries
(the
Democratic Republic of Congo, Somalia, South Sudan and Sudan), but with flexibility to conduct data collection
in new emergencies and other settings where existing collaborations facilitate this. We present below a set of
activities and studies organised along three aims:
Aim 1: Establish or strengthen
country-based, locally-led, multi-disciplinary humanitarian public health research
units
in the four key countries.
Aim 2: Explore novel cross-cutting methods based on
community-led surveillance
and
data science methods
.
Aim 3: Generate thematic evidence on the direct and indirect impacts of COVID-19 and other emergent public
health threats, as per the following scientific objectives:
1. Generate improved all-cause and cause-specific
2. Quantify of SARS-CoV-2 and other epidemic infections.
3. Explore changes to behaviours, improve monitoring of hygiene behaviours and evaluate
mortality
estimates.
transmission
hygiene
alternative behaviour change interventions.
4. Quantify and describe COVID-19’s secondary impacts on
5. Quantify COVID-19’s impacts on
care models.
sexual and reproductive health
.
non-communicable disease burden and mental health
and test novel
These activities will be undertaken by a
consortium of academic institutions
(the London School of Hygiene and
Tropical Medicine, London, UK; the Université Catholique de Bukavu, DRC; SIMAD University, Mogadishu,
Somalia; Imperial College London) and (the Bridge Network Organisation, South Sudan; the
Sudan Youth Peer Network and Adeela for Art and Culture, Sudan). Our partnership is committed to co-
production principles and will adopt a decolonial approach to research and humanitarian action. Most team
members are former humanitarian workers, and all conduct the majority or all of their research work in or on
crisis-affected populations.
civil society actors

Public health relevance
Project narrative We propose a five-year programme of capacity strengthening and research to (i) strengthen country-based capacity for timely, agile public health research in four countries affected by large protracted crises; (ii) explore novel cross-cutting methods including community-led mortality and epidemic surveillance, and data science applications; and (iii) generate key evidence on different thematic areas including mortality, transmission of SARS-CoV-2 and other epidemic threats, improved hygiene behaviour measures and interventions, measurement of the indirect impacts of the pandemic on sexual and reproductive health among young and adolescent girls, and quantification of impacts on non-communicable diseases and mental health, with evaluation of novel care models for these health problems.